Development, Validation, and Application of Structure-based Tools for Computational Molecular Design

PROJECT SUMMARY/ABSTRACT
The central objectives of our MIRA research program are "development" and "validation" of methodologies to
algorithmically encode underlying physical observables to improve design of small organic molecules for a
biological target. Computational modeling at the atomic-level empowers understanding of the factors that drive
molecular recognition, and "application" to real world systems enables testable predictions. Grounded in strong
results, data, and demonstrated productivity, we hypothesize that major gaps in the field (e.g. design of ligands
with optimal target complementarity, sampling/searching challenges, protein specificity, incorporating
cheminformatics during design, lack of intelligent automated-methods for refinement, lack of methods for
covalent de novo design, difficult to use software) can be bridged through forward-thinking design of new
computational tools. As the lead developer of the widely-used program DOCK6, in major undertakings, we are
developing powerful paradigms for "de novo design" and "molecular evolution" that logically drive ligand
construction to drug-like space using clever scoring functions and cheminformatics descriptors simultaneously.
Our platforms remove the limitation of only considering ligands that are preconceived, and promote the design
of compounds that are highly optimized and "specifically tailored" to the protein(s) of interest. Our approach is
centered around fragment-based assembly and searching using customizable building block libraries for "from-
scratch" construction and "refinement". Our advances are made available to the research community through
regular public release (we led the last seven DOCK6 releases 6.4-6.10) along with validation databases and
user-friendly tutorials. A new webserver will enable novice, intermediate, and expert users alike more direct
access to our tools. Our expected outcomes are cutting-edge software and identification of highly specific and
optimized ligands. The proposal is framed around 4 fundamental questions: (Q1) Can the principles that drive
molecular recognition be captured at the atomic level and used to design improved software for more accurate
prediction of geometry and energy? (Q2) Can ligand growth be propelled to highly specific regions of chemical
space using clever from-scratch assembly (de novo design) and Darwinian principles (molecular evolution)?
(Q3) Can more "intelligent" sampling, scoring, and searching methods be developed for identification and design
of verified-active compounds in collaboration with experimentalists? (Q4) Can docking and de novo design
software and protocols be designed to be more "user friendly" while not sacrificing accuracy or power? We
collaborate with a network of experienced experimental labs to (i) validate theoretical predictions, (ii) answer
basic research questions, (iii) provide mechanistic understanding, and (iv) identify new agents against clinically
relevant targets involved in cancer (fatty acid binding protein, neutral ceramidase, EGFR, HER2), viral entry
(HIV, Zika, Ebola), multi-drug bacterial resistance (LpxC), and fungal infection (Sgl1, SglA, S1Pr3), among
others. Experimental outcomes, in turn, will inform our further method development efforts.

Public health relevance
PROJECT NARRATIVE The goal of our research program is to develop and validate new sampling, scoring, and chemical searching techniques, for more accurate prediction of molecular recognition at the atomic level, to enable greater understanding of biological systems relevant to public health. We are creating new molecular assembly platforms to facilitate from-scratch construction (de novo design, molecular evolution) of small organic molecules with cheminformatics properties customized to the binding site(s) being targeted. We apply our tools to make testable predictions in collaboration with experimental groups, and we make them widely available to the research community.